Understanding the relationship between female reproductive span and dementia risk

PROJECT SUMMARY
Despite robust evidence for a sex difference in Alzheimer’s disease and related dementias (ADRD), the
mechanisms behind this difference remain poorly understood. Given that reproductive hormones are a central
determinant of sex differences in brain structure and function, we hypothesize that factors that influence
lifetime reproductive hormone exposure (in particular estrogen exposure) are critical to understanding the
development of ADRD in women. The goal of the proposed study is to utilize existing data from the Swedish
Twin Registry – one of the largest population-based twin registries in the world – in order to understand the
genetic and environmental relationships underlying the association between female reproductive history and
ADRD. In Aim 1 we will use conventional and new data analytic methods to elucidate the degree to which the
association between female reproductive span and ADRD is due to shared genetic and environmental factors.
The genetic analysis of ADRD, and by extension any analysis which seeks to determine the degree of genetic
overlap with ADRD, is complicated by the fact that the relative risk of ADRD varies dramatically by age. We
will develop a genetically-informative survival analysis method to estimate the genetic and environmental
determinants of ADRD, as well as genetic and environmental correlations with reproductive span. In Aim 2, we
will test whether female reproductive span modifies the genetic and environmental determinants of ADRD.
Reproductive hormones like estrogen primarily exert their physiological influence by binding to hormone
receptors, which in turn modulate the expression of downstream genes. We hypothesize that due to this
mechanism, the heritability of ADRD will vary as a function of female reproductive span. In Aim 3, we will
determine how key women’s health factors – oral contraceptive use, parity, surgical menopause, and hormone
replacement therapy – impact the association between reproductive span and ADRD. We hypothesize that
these factors, which are crucial to understanding women’s health across the lifespan, will impact ADRD risk by
modifying the degree of lifetime estrogen exposure. This proposal will advance the field’s understanding of
how female reproductive history contributes to the etiology of ADRD by providing the first genetically-informed
analysis of the relationship between female reproductive span and ADRD conducted in twins, developing
analytic methods that are essential to genetically-informed analysis of ADRD, testing novel hypotheses
regarding whether lifetime estrogen exposure influences the genetic and environmental determinants of ADRD,
and finally determining how factors common to female reproductive history influence the relationship between
reproductive span and ADRD. The NIH has placed a major emphasis on the need for researchers to treat sex
as a biological variable, and to focus on those factors that contribute to sex differences in health and disease.
The proposed study directly confronts this issue by examining the impact of female reproductive history – a
major determinant of women’s health later in life – on ADRD risk.

Public health relevance
PROJECT NARRATIVE As research into Alzheimer’s disease and related dementias (ADRD) continues to shift towards the early identification of biological markers and symptom onset, the importance of understanding the impact of female reproductive history cannot be stressed enough, as some of its most pronounced events (e.g., the menopausal transition) coincide with the critical midlife window where therapeutic interventions or preventative strategies are expected to be the most effective. The proposed study will elucidate the genetic and environmental relationships underlying the association between female reproductive history and ADRD, and through the use of innovative data analytic methods, test novel hypotheses regarding the nature of the association. This study will generate hypotheses and preliminary data necessary for the development of a broader, genetically informed research program that targets the origins of sex differences in ADRD, in particular those factors that are of utmost importance to women’s health.